Control of glucose homeostasis through the insulin-independent Isthmin pathway

PROJECT SUMMARY
Chronic metabolic dysfunction has emerged as one of the most severe medical problems worldwide, leading
to increases in type 2 diabetes, insulin resistance, and cardiovascular disease. The discovery of alternative
pathways to regulate whole-body glucose and energy metabolism is urgently needed to address this great
medical need. Such pathways could be exploited for new therapeutic strategies to combat diabetes and
insulin resistance. Using a multidisciplinary strategy combining computational, cellular, and in vivo
approaches, we have recently uncovered a new adipokine from thermogenic adipose, Isthmin-1 (Ism1), that
acts to promote glucose uptake in mouse and human adipocytes. The action of Ism1 requires PI3K/AKT
signaling but is entirely independent of the insulin receptor. In animals rendered diabetic by high-fat diet
feeding, administration of recombinant Ism1 protein or genetic elevation of circulating Ism1 improves
glucose homeostasis. However, more studies are needed in order to understand the contribution of Ism1 to
glucose metabolism, and to leverage this understanding for therapeutic purposes. The overall objectives in
this proposal are to establish how Ism1 can control blood glucose by determining the signaling effectors and
cell surface receptor that mediate the action, determine the endogenous physiological function for Ism1, and
evaluate the pharmacological potential of Ism1 as a therapeutic target. In Aim 1, we will utilize biochemical,
genetic, and proteomic methods to identify the signaling pathways and cell surface receptor responsible for
the signaling action and glucoregulatory mechanisms of Ism1. These studies will identify Ism1’s mechanism
of action and will be critical for our understanding of Ism1 signaling as an insulin-independent pathway to
regulate glucose uptake. In Aim 2, we will determine the physiological function for Ism1 using our generated
whole-body and adipocyte-specific Ism1 knockout mice. These studies are essential in determining the
endogenous role of Ism1 in glucose metabolism. In Aim 3, we will determine the minimal requirements for
Ism1 bioactivity by generating fragments, mutants, and engineered forms of Ism1. This aim will pave the
way for further optimization of a polypeptide hormone as a therapeutic agent, and will be essential in
understanding the effects of augmentation of this novel pathway physiology. These contributions are
expected to be significant because pathways that can regulate glucose independently of insulin will open
entirely new avenues to overcome insulin resistance and diabetes, which could have a significant public
health impact.

Public health relevance
NARRATIVE There is a pressing need for new therapies for obesity and type 2 diabetes, either alone or to complement current treatments. This proposal will establish the molecular mechanisms underlying control of glucose homeostasis by a newly discovered adipokine. Our project is anticipated to lead to a better understanding of how glucose is regulated by insulin-independent pathways, ultimately leading to facilitate the translation to human clinical applications.